Diagnosing the Unknown for Care and Advancing Science (DUCAS)

PROJECT SUMMARY
In our current healthcare system, it often takes years before patients with rare conditions and rare
presentations of common conditions receive a diagnosis. In 2013, the National Institutes of Health supported
the creation of the Undiagnosed Diseases Network (UDN) to address the needs of these patients, to facilitate
the diagnostic process for those with undiagnosed conditions and generate new knowledge about underlying
mechanisms of disease. The UDN was successful in solving medical mysteries, shortening diagnostic
odysseys, and contributing to biomedical research discovery. In order to serve more patients, the UDN process
must be scaled and integrated into broader healthcare and research ecosystems. As the Data Management
Coordinating Center (DMCC) for a network of Diagnostic Centers of Excellence, Harvard Medical School will
leverage experience in the UDN to create sustainable, nationally scaled infrastructure to support diagnosis,
research, and care for those who are undiagnosed. This will be accomplished by bringing together experts in
trans-institutional data sharing, data analysis, clinical care, bioinformatics, novel diagnostics, and translational
research and creating three DMCC Cores - Administrative, Data Management, and Clinical Research Support -
to address unmet needs of the undiagnosed. The Administrative Core will unite the DMCC and support
activities of all three Cores. Together, the DMCC Cores will accomplish four aims: 1) Scale up UDN throughput
by at least an order of magnitude to meet a pressing national need, 2) Leverage partnerships for sustainable
coordination of diagnostic processes to increase patient autonomy while advancing opportunities for
investigative science, 3) Maximize data mobility, interpretability, and shareability, and 4) Provide analytic
service and data stewardship through the Data Management Core and Clinical Research Support Cores led by
experts in genomics and AI teaming with clinicians and researchers.

Public health relevance
PROJECT NARRATIVE Without access to an integrated approach to diagnosis, research, and care, many patients with rare conditions go from one institution to the next without finding answers or making progress with their care. This leads to poor outcomes for patients and families and poses a burden on our healthcare system. As part of this project, we will create sustainable, national infrastructure to address this unmet need for those who are undiagnosed.